Regulation of Cardiac Fibrosis in Heart Failure by the Cytokine FAM3D

PROJECT SUMMARY / ABSTRACT:
Heart failure (HF) is a major public health concern with increasing prevalence in the United States and
globally, particularly in the elderly, for whom it represents the leading cause of hospitalization. While
dysregulated inflammation, cardiac fibrosis, and neurohormonal activation are observed in the maladaptive
remodeling of HF, the precise molecular mechanisms that underlie these cellular phenomena are
incompletely understood. Interestingly, the salutary effects of exercise have been shown to slow or even
reverse the functional decline of HF both in humans and in animal models. This research proposal outlines
a 2-year plan for the Principal Investigator, Dr. James Rhee, M.D., Ph.D., Director of Neuroanesthesia at
Massachusetts General Hospital (MGH) and Assistant Professor at Harvard Medical School (HMS), to
lead a team of expert scientists in studying the role of the cytokine Family with sequence similarity 3
member D (FAM3D) in heart failure. Dr. Rhee has previously identified FAM3D as highly upregulated in
the plasma of patients who experienced favorable cardiac remodeling and restoration of function after
heart attack. In animal models of cardiac ischemia reperfusion injury, FAM3D overexpression limited infarct
size by suppressing inflammatory cell trafficking into the damaged myocardium. Presented in this current
proposal are compelling data showing that FAM3D directly regulates cardiofibroblast activation. Its anti-
inflammatory and anti-fibrotic roles overlap with those observed in the hearts of exercise-trained mice.
Given its constellation of effects on immune cells and fibroblasts in limiting injury and promoting recovery,
FAM3D likely possesses multifactorial benefits in curtailing the progression of HF. Dr. Rhee and his team
will rigorously interrogate how this cytokine governs non-immune cells in the heart, namely fibroblasts and
lymphatic endothelial cells. They will carefully assess how gain or loss of FAM3D affects cardiac function
in two widely used animal models of HF, namely that of pressure overload (Aim 1) and aging (Aim 2), and
any requirement for TGF-3 as a downstream signal. The research team will also manipulate FAM3D in
the aging heart in the setting of exercise. There will be special emphasis placed on the characterization of
the cardiac lymphatic system, which has received increasing attention as an integral component of
myocardial health and is intimately tied to both inflammation and fibrosis. The approach herein combines
innovative hypotheses, unique technologies and animal models, and collaborating investigators who
possess highly specialized skillsets. Completion of these studies will provide valuable insight into the
pathogenesis of HF, and lead to the identification of promising new therapeutic targets.

Public health relevance
PROJECT NARRATIVE: Heart failure (HF) is a leading cause of morbidity and mortality in an increasingly older population in the United States. This proposal will allow a team of expert scientists and clinicians to comprehensively interrogate a multifaceted cytokine that confers both anti-inflammatory and anti- fibrotic effects in different animal models of HF. The successful completion of these studies will offer novel insight into the molecular mechanisms underlying HF, identify new targets for therapeutic intervention, and help fulfill the NIH/NHLBI's missions to develop knowledge in combating illness and promoting public health.